Core C: University of Kentucky Alzheimer's Disease Core Center

Project Summary/Abstract: Data Management and Statistics Core
The Data Management and Statistics (DMS) Core can be conceptualized as the lynchpin for integration of the
ADRC Cores and is vital to the success of the UK-ADRC. Its critical roles include managing a large centralized
database, consulting with ADRC-affiliated researchers, and working to develop and apply innovative statistical
methodology for data analysis. Data management efforts focus on collecting, storing, and sharing high quality
data using a web-based platform. This focus begins with the leadership and vision and attention to detail
provided by the DMS Core. This core has an enviable track record of timely and accurate reporting of a high
volume of data to NACC. Further, weekly Core meetings are popular with UK-ADRC investigators who find that
the expert advice provided by our seasoned investigators improves their success in pilot studies, grant
applications, and publications. The Core also participates as a full partner to the research mission of the UK-
ADRC emphasizing transitions in late life from normal to multiple etiology dementia. A key element of this
Core is the well-established track record of developing novel methodology to analyze data collected at the UK-
ADRC and from other cohorts with a focus on elderly subjects’ transitions to MCI and eventually dementia. The
Core also provides training for students enrolled in the graduate programs in Gerontology, Public Health,
Epidemiology and Biostatistics, Psychology, and Statistics. It is committed to developing younger faculty to
become productive ADRC investigators. In keeping with the mission of the UK-ADRC, faculty in this Core also
contribute to the dementia research community at large through service on external advisory committees,
study sections, manuscript reviews, and data safety monitoring boards. The DMS Core will continue these
critical responsibilities through the following specific aims.
Aim 1: Maintain and expand an integrated data warehouse and suite of web-based data collection applications
and reporting platforms for ADRC Cores and projects.
Aim 2: Provide expertise on experimental design and statistical analysis.
Aim 3: Support the clinical, biomarker, neuropathological, educational, and outreach missions of the ADRC.
Aim 4: Contribute to the activities of the dementia community at large through service and research.

Public health relevance
Per RFA-AG-21-019: Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.